Developmental origins of mental illness: evolution and reversibility

Overall abstract
Most mental illnesses emerge during vulnerable windows of brain development to impact cognitive function in
humans. While hundreds of genes and/or environmental factors have been linked to mental illnesses, even
neighboring point mutations on a single gene (eg. Shank3) can lead to `early' disorders such as autism or `late'
schizophrenia. This poses a double challenge to understanding their etiology and potential treatment – how to
track the trajectory of circuit derailment and the relevance of such studies in animals like mice whose cognitive
skills may be less well-characterized. Our proposed Conte Center renewal will tackle these problems directly
by uniting four pioneering neurobiologists focused on the formation and refinement of neuronal circuits in two
stages of development, fetal and pre-adolescent critical periods. Our central hypothesis is that whatever the
predisposing environmental factors or genetic bases, the proximate cause of aberrant behavior in cognitive
disorders will be found in distinct patterns of altered neuronal connectivity. First, to examine how excitatory-
inhibitory balance is established in fetal life, Arlotta combines cutting edge stem cell, genomic, imaging and
physiological recording technology for the longitudinal study of human brain organoids carrying specific gene
mutation. Second, key conceptual insights from Hensch in the first phase of our Center identified the pivotal
role of parvalbumin (PV+) cells in determining postnatal critical period timing. Because of their high metabolic
activity, PV+ cells are vulnerable to oxidative stress in mental illness, as are the gamma oscillations which they
generate (in association with cognition). Manipulations altering PV+ cell maturational profiles powerfully shift
plastic windows in sensory cortex, indicating that malleability of critical periods themselves may contribute to
cognitive disorders as well. Third, Hensch and Feng confirmed an impairment of multisensory integration in the
insular cortex of mice carrying autism risk mutations in Shank3 and Mecp2. Notably, these lie on opposite ends
of PV+ circuit hypo- or hyper-maturation. Here, we will take advantage of reversible and conditional genetic
mutations in these genes to map critical periods for other higher functions of relevance: attention, cognitive
flexibility, and social preference– all established in the Hensch lab. Moreover, for direct comparison to his mice,
Feng will produce marmosets carrying Cre recombinase in PV+ cells or Shank3 deletion using CRISPR
technology. His unique infrastructure will enable manipulation and analysis of the same circuits in this primate
with better evolved frontal cortex and behaviors. Fourth, we capitalize on a sophisticated platform for complete
3D electron microscopic circuit reconstruction established by Lichtman during the first phase of our Center to
compare and contrast the emergence of `connectopathies' from human organoids to mice and marmosets.
Ultimately, reducing the stigma of mental illness through state-of-the-art neuroscience to train the next
generation and conveying this knowledge through our strong, active Outreach program is the primary mission
of the Conte Center at Harvard.

Public health relevance
Narrative When a complex machine such as a car malfunctions, the first thing a mechanic must do is identify the origin of the problem. It's hard to fix things without knowing what's broken. This challenge plagues the understanding and treatment of mental illness. The Conte Center at Harvard seeks to revolutionize therapy and prevention by addressing two necessarily basic questions: What does mental illness look like in the brain? When and how during development do these differences arise? In our first phase, we established state-of-the-art technologies to fully reconstruct brain circuits and made conceptual advances into the biological basis of critical periods of vulnerability. Now reconfiguring around the laboratories of Arlotta, Lichtman, Hensch and Feng, our world class team tightly integrates across levels from behavior to circuits, cells, synapses, and genes, to understand what is different about a brain that produces the symptoms of schizophrenia or autism, for instance, versus one that does not. Focusing on the potential to rescue Shank3 or Mecp2 mutations, we span diverse systems from human organoids to reversible gene-targeting in mice and transgenic marmosets to track the trajectory from fetal development to cognitive impairment. Further, by leveraging our highly regarded Outreach infrastructure established in the first phase, our trainees will increase public awareness and build a pipeline of future investigators as they engage in this unparalleled research themselves.